Career Enhancement Core

CAREER ENHANCEMENT CORE: SUMMARY/ABSTRACT Virginia M. Miller, Ph.D.
The aims for the Career Enhancement Core (CEC) in this renewal application for the Mayo Clinic Specialized
Center of Research of Excellence (SCORE) on Sex Differences are a natural extension of activities begun
under the previous funding cycle. The three aims of the CEC in this renewal application focus on the long-term
sustainability of programs in women's health and sex-differences research: 1) to develop the next generation of
clinical and basic researchers, 2) to provide leadership and development of best practices and policies in
biomedical research aimed toward understanding diverse health outcomes, and 3) to serve as a vital hub for
the education and dissemination of innovative sex-based translational research methods, results, and best
practices. The leadership development begins with assuring that there is appropriate transitional leadership for
the program through: a) deliberate mentorship of senior investigators in management skills, b) fostering
research careers of newer investigators involved with the SCORE through mentoring and funds for ancillary
studies to the SCORE projects, and c) stimulus grants open to the research community to broaden the scope
of research into sex-differences across the Mayo Clinic Enterprise, including collaboration with the Mayo Clinic
Center for Individualized Medicine and the Mayo Clinic Office of Health Disparities Research. Our SCORE
Investigators are providing insight into best practices and policies through various venues, and have a proven
track record of publications related to sex-differences methodology and research visioning. In addition, during
the previous funding cycle, our investigators have established collaborative and synergistic programs with
other NIH-funded Mayo Clinic resources and mentoring programs such as Building Interdisciplinary Careers in
Women's Health (BIRCWH) and the Center for Clinical and Translational Science Program (CCaTS). During
the renewal funding cycle, initiatives to develop curricula in sex- and gender-medicine will be continued and
formalized. Research findings and best practices will continue to be disseminated through research symposia
locally and at national professional meetings. The past productivity, the past successes, and the diversity of the
Mayo Clinic SCORE Investigators, which represents over thirteen departments and divisions and multiple
professional societies, assures the sustainability and the far reaching influence of our program on the future of
research on women's health and sex-differences.

Public health relevance
CAREER ENHANCEMENT CORE: PROJECT NARRATIVE Virginia M. Miller, Ph.D. The Mayo Clinic Career Enhancement Core for the Specialized Center of Research Excellence on Sex Differences is designed to train and develop leaders and researchers in women's health and sex and gender differences through a three-tiered approach: nurturing leadership, supporting on-going research, and stimulating new research. This Core will provide targeted training in research methodology of sex-differences. Finally, the Core will provide essential dissemination of new findings in women's health and sex-differences research into graduate and medical educational curricula so that the next generation of health care providers can implement these findings to improve health care for women and men.